Circuit-specific tau burden and mechanisms of sleep-dependent memory processing in older adults at risk for Alzheimer’s disease

PROJECT SUMMARY
Alzheimer’s disease is a progressive neurodegenerative disorder characterized by the accumulation of beta-
amyloid (Aβ) plaques and neurofibrillary tau tangles. While Aβ is an important Alzheimer’s disease risk factor,
tau is more closely tied to cognitive outcomes. Tau pathology accumulates locally and spreads through specific
brain circuits, initially aggregating within the hippocampal (HC)-entorhinal cortex (EC) circuit and impairing
episodic memory. New data, including our own, indicate that the basal forebrain (BF) and amygdala (AMY),
regions supporting emotional memory processing, are also early sites of tau deposition. Whether tau deposition
within these circuits contributes to distinct impairments in emotional and non-emotional memory function is
unknown. HC-EC and BF-AMY circuits exhibit different brain network dynamics, express discrete facets of non-
rapid eye movement (NREM) and REM sleep oscillatory activity, and support distinct aspects of sleep-dependent
memory consolidation (SDMC). It is possible that tau deposition within these circuits results in deficits in sleep
expression as well as dynamic network architecture important for SDMC. To address these critical knowledge
gaps, we will use an innovative multimodal neuroimaging design combining high-resolution positron emission
tomography with a novel [18F]MK-6240 tau tracer, polysomnography with high-density electroencephalography,
and high-resolution resting-state functional magnetic resonance imaging combined with a memory task taxing
HC-AMY function. Using these methods, we will test the novel hypothesis that local tau deposition within these
circuits is associated with distinct deficits in sleep expression, dynamic resting state network architecture, and
SDMC in cognitively unimpaired Aβ+ older adults. In Aim 1, we will test two hypotheses: (1) HC-EC tau will be
associated with deficits in NREM slow wave-spindle coupling, which will be associated with impaired overnight
memory retention across valence. (2) BF-AMY tau will be associated with reduced REM theta, which will be
associated with impaired overnight retention of emotional memories. In Aim 2, will test three hypotheses. (1) HC-
EC and BF-AMY tau will be associated with decreased network modularity, which will be associated with
impaired SDMC. (2) HC-EC tau will be associated with reduced HC-EC flexibility, which will be associated with
diminished sleep-dependent consolidation of non-emotional memories. (3) BF-AMY tau will be associated with
lower BF-AMY flexibility, which will be associated with diminished emotional memory consolidation. We will also
use mediation models to test if regional tau pathology impacts memory consolidation through these hypothesized
mechanisms. Findings from the proposed study will provide novel insight into the mechanisms contributing to
distinct deficits in SDMC in older adults at risk for Alzheimer’s disease, potentially guiding prospective
intervention studies to minimize cognitive decline associated with Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE The aggregation of Alzheimer’s disease (AD) tau pathology occurs in a circuit-specific fashion, which may disrupt non-rapid eye movement (NREM) and rapid-eye movement (REM) sleep expression and dynamic network organization to impair sleep-dependent memory processing, but this has never been directly tested. Our study will assess whether circuit-specific tau deposition is differentially associated with distinct deficits in NREM and REM sleep oscillations, dynamic resting state network architecture, and emotional and non- emotional memory consolidation in older adults at risk for AD. Findings from the proposed study will provide a novel mechanistic account for AD-related memory impairments and memory biases contributing to susceptibility to mood disturbance and emotion dysregulation in AD, which could help to guide prospective preclinical intervention studies to delay or prevent early symptoms of AD progression.